Discovery and optimization of novel diamine derivatives as HIV-1 entry inhibitors

DESCRIPTION: The goal of this proposal is the optimization of newly discovered HIV-1 entry inhibitors and elucidation of their broad mechanism of action. HIV-1 infection begins when the envelope glycoprotein gp120 binds to the cell surface receptor CD4. This initial binding event results in a series of allosteric events from activation of the co- receptor site, subsequent binding to the chemokine co-receptor (CCR5 or CXCR4), fusogenic conformation of gp41, and finally fusion of the viral and cell membranes. As the process of entry is key to the replication o the virus, it is one of the most important targets in the search for new drugs to treat HIV-1 infection. Advances in knowledge of the molecular mechanisms of HIV-1 entry have allowed the discovery and development of molecules that block each step of the entry process and that have been successfully used in the clinic, e.g., maraviroc (Selzentry, Pfizer, New York, NY) and enfuvirtide (Fuzeon, Hoffman-La Roche, Nutley, NJ). To date, however, no gp120-targeted therapies have been approved for use in the clinic. Using an innovative high- content pharmacophore approach, we have discovered SC03, a new entry inhibitor that shows micromolar potency in a single-round infection assay. Bioisosteric replacement of a central piperazine and an acenaphthene moiety in this compound has led to the identification of compound SC08 - a novel entry inhibitor with a new chemotype and sub-micromolar potency. We will combine medicinal chemistry with computer-aided drug design (CADD) and biological testing for potency, selectivity, and toxicity. Our approach integrates high- content pharmacophore mapping and three-dimensional quantitative structure-activity relationships, chemical synthesis, direct binding assays using recombinant wild-type and mutant HIV gp120 variants, and single-round infection assays using virus pseudotyped with envelopes from genetically disparate primary HIV isolates. The toxicity of compounds will be tested using uninfected PBMCs as well as 293T and U87 cells to assess therapeutic index. The success of this project will provide novel potent and selective HIV-1 entry inhibitors that may ultimately expand the anti-HIV armamentarium.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposal seeks to design novel HIV-1 entry inhibitors using a multidisciplinary approach. The small molecules identified within this study will represent novel reagents that can be used to probe the mechanism of entry of HIV-1 into the host cell and hold promise for the development of a new class of anti-HIV agents. __SpecificAimsTextDelimiter__ RESEARCH PLAN 1. Specific Aims The goal of this proposal is to optimize newly discovered HIV-1 entry inhibitors and elucidate their broad mechanism of action. HIV-1 infection begins when the envelope glycoprotein gp120 binds to the cell surface receptor CD4. This initial binding event results in a series of allosteric events from activation of the co-receptor site, subsequent binding to the chemokine co-receptor (CCR5 or CXCR4), fusogenic conformation of gp41, and finally fusion of the viral and cell membranes. As the process of entry is key to the replication of the virus, it is one of the most important targets in the search for new drugs to treat HIV-1 infection. Advances in knowledge of the molecular mechanisms of HIV-1 entry have allowed the discovery and development of molecules that block each step of the entry process and that have been successfully used in the clinic, e.g., maraviroc (Selzentry, Pfizer, New York, NY) and enfuvirtide (Fuzeon, Hoffman-La Roche, Nutley, NJ). To date, however, no gp120-targeted therapies have been approved for use in the clinic. SC03 is a new entry inhibitor that shows micromolar potency in the single-round infection assay, discovered using a high-content pharmacophore in silico screening approach. The novel inhibitor SC04, found through bioisosteric replacement of the central piperazine core, shows similar potency in a multiple round infection assay and provides a proprietary lead structure. Further improvement of SC04 by substitution of the acenaphthene moiety with 4,7-dimethoxy-1H-pyrrolo[2,3-c]pyridine, has lead to SC08, a compound with sub- micromolar potency and a novel chemotype. Further lead optimization based around the SC04 scaffold will improve potency around this chemotype and assess the potential to effectively treat HIV-1 infection. Medicinal chemistry, SAR analysis and rational drug design of analogues necessary for the SC04 lead optimization efforts will be performed in collaboration with and contracted out to AsisChem, Inc. (Waltham, MA) a fully- equipped contract chemistry services company with experienced PhD-level synthetic organic chemists and large Pharma-trained medicinal chemists. Furthermore AsisChem has the prior experience of having successfully synthesized and purified our current best inhibitor, SC08. We therefore present a multidisciplinary research plan that is comprised of two discrete but interlinked aims outlined below. Specific Aim 1. Increase potency of the SC04-type entry inhibitor. Based on discussions with HIV-1 clinicians at DrexelMed, an in vitro Target Product Profile (TPP) was elaborated, based on the following criteria: (i) Biological activity: potency with median IC50 values d10 nM against HIV-1 subtypes A, B, and C; and specificity with AMLV/VSV-G IC50/HIV-1 IC50 ratio e10,000; (ii) Toxicity: CC50 e500 μM against uninfected PBMCs as well as 293T and U87 cells; and (iii) Drug-like properties: solubility e100 mg/ml and cLogP between 1 and 3.5. SC04 analogues with improved potency and drug-like properties will emerge from Topliss tree structure-activity relationship (SAR) optimization of the bicyclic heterocycle ring through judicial addition of halogens, along with electron-donating and electron-withdrawing substitutions, and bioisosteric replacements. Moreover, additional bioisosteric piperazine ring system replacements for the central core will be explored and are predicted to improve drug-like properties, as well as provide increased novelty. We have already shown the validity of this approach by the generation of compound SC08. All compounds generated will be assessed in single-round infection assays using recombinant virus pseudotyped with the HIV-1YU-2 envelope glycoproteins. Once antiviral effect is shown against HIV-1YU-2, select clade A, B, and C viruses will be included to establish median IC50 values. Amphotropic murine leukemia virus (AMLV) envelope glycoprotein pseudotyped HIV-1 will also be included to test specificity of the compounds to HIV-1. This aim will identify second-generation small molecules that target the process of HIV-1 entry, exhibit more potent antiviral activity with minimal cellular toxicity, and thus warrant further mechanistic investigation. Specific Aim 2. Elucidate the mechanism of inhibition of HIV-1 entry by SC04 and its higher-potency analogues. Due to the conformational flexibility of the target, compounds that interact with gp120 can have multiple effects on receptor recognition by this protein. Compounds could have no effect or could have an inhibitory or an enhancing effect on the interactions of gp120 with CD4, CCR5, or co-receptor surrogate antibodies. Using surface plasmon resonance (SPR) assays developed in our laboratory, we will assess the direct binding, CD4 inhibition, and co-receptor-binding surface exposure properties of the higher-efficacy SC04 analogues. Use of wild-type and mutant HIV-1 gp120s in such assays will facilitate the identification of groups on the analogues responsible for affinity and will also aid in the delineation of the compounds' binding sites. This aim will provide key information on the mechanism of action and binding sites of SC04 and its higher-potency derivatives. The success of this project will provide novel potent and selective HIV-1 entry inhibitors that may ultimately expand the anti-HIV armamentarium, whilst providing additional chemical probes for dissection of the viral entry process.